Universal HCV screening in pregnancy: Examining testing uptake and HCV care

PROJECT ABSTRACT:
Hepatitis C virus (HCV) during pregnancy predominantly affects people who inject drugs. The rates of perinatal
HCV and maternal to child transmission are rising in concert with the current injection drug use crisis. Testing
for HCV in the perinatal period has been inadequate, as has testing of infants born to mothers infected with
HCV. To improve testing rates, several professional societies released guidance recommend universal HCV
testing with each pregnancy in spring of 2020. However, screening recommendations are not universally
followed, and may not be applied equitably across populations. Additionally, we do not know whether an
increase in testing ultimately leads to the desired downstream outcomes of linkage to care, treatment, and
identification of infants at risk for perinatal transmission. In this proposal, we will use national Medicaid and
commercial claims data to examine HCV testing and treatment among pregnant and postpartum women and
their infants. Specifically, we will 1) determine whether the testing guideline change was associated with
increased HCV testing rates among pregnant women compared to non-pregnant reproductive age women; 2)
determine whether the guideline change was associated with increased postpartum HCV linkage to care and
treatment as well as other aspects of maternal care, and 3) determine whether the guidelines were associated
with increases in appropriate HCV testing and diagnoses for infants born to HCV-infected mothers in Medicaid.
In each aim, we will examine variation in the implementation of HCV testing, identifying targets for further
public health and policy intervention. Understanding the landscape of HCV testing for the perinatal population
is critical for eliminating HCV and improving the lifetime health of people who use drugs.

Public health relevance
PROJECT NARRATIVE Hepatitis C virus infection has an increasing burden among pregnant and postpartum women, with the main risk group being women who use drugs. Recent clinical guideline changes recommended universal screening during each pregnancy, but we do not know if these guidelines have been widely implemented. We will apply rigorous econometric methods to national claims data to determine the extent to which the guideline update is related to increases in hepatitis C testing, treatment, and diagnosis of maternal to child transmission.